Long-Term Opioid Therapy: Screen to Evaluate and Treat (Opioid-SET)

Background: Despite high numbers of VHA patients (>300,000) receiving long-term opioid therapy (LTOT),
evidence of its harms is growing (e.g., inadequate pain control, side effects, overdoses). Although VA/DoD
Guidelines recommend frequent, multi-component monitoring of LTOT patients, monitoring is under-utilized
because it does not fit with primary care’s workflow. In addition, rates of opioid discontinuation are increasing,
even though discontinuation is often harmful (e.g., more use of street heroin, worsening mental health).
Further, for patients for whom both continued LTOT and tapering for discontinuation are determined to be
potentially harmful, a clinical practice guideline (CPG) is not available, leaving them “guideline-orphaned.”
Significance: With increasing opioid overdose deaths and complications of LTOT due to comorbidities, policy
emphases have shifted to reducing opioid prescribing, and monitoring and discontinuing opioids among LTOT
patients. This project will help providers maintain high-quality patient care while responding to policy shifts. It
addresses the VHA’s and HSR&D’s goal of offering patient-centered care by giving providers an integrated
instrument to reduce harms due to LTOT continuation and discontinuation, which are widespread and severe
among Veterans. Innovation: This project has the potential to change LTOT practices by giving primary care
and other providers new, easy-to-use screening tools that will facilitate adherence to recommended guidelines
on monitoring of LTOT patients, and discontinuation of LTOT when it is harmful. The integrated instrument may
be incorporated into CPRS to facilitate its use in VA health care clinics. The project will also change practice by
providing new, provisional guidelines for a challenging group of LTOT patients for whom CPGs do not exist.
The work to be accomplished is complementary to VHA initiatives by contributing to components of best
practices for balancing pain management and opioid prescribing, “S.T.O.P. P.A.I.N,” i.e., Stepped care model;
Treatment alternatives; Ongoing monitoring of usage; and Practice guidelines. Specific Aims are to develop an
integrated instrument with two screening tools, the first to indicate if LTOT is harmful to continue (yes or no;
Aim 1), and the second to indicate if tapering to discontinue opioids is harmful to initiate (yes or no; Aim 2).
Positive screens will indicate that providers should undertake additional, more comprehensive monitoring and
examination to determine the harm of continued LTOT or tapering to discontinuation, respectively. Aim 3:
Inform subsequent CPGs by determining preliminary treatment approaches for “guideline-orphaned” LTOT
patients. Methods to develop the tools will involve (1) comprehensive literature searches to yield an initial item
bank for each screening tool; (2) qualitative item analyses using focus groups with patients and providers,
cognitive interviewing with patients, expert review, and item revision to yield small item banks for each
screening tool for field testing; and (3) field testing to yield the final bank of items for each screening tool, which
will include (a) linking patients’ (n=500 for each tool) telephone survey responses to their electronic health
record data from the Corporate Data Warehouse, and (b) reliability testing (n=30 patients). Methods to work
toward the CPG will follow the same methods used to develop the VA/DoD CPG for the Management of
Substance Use Disorders, which consist of (1) conducting a systematic review, (2) obtaining input from the
expert reviewers, and (3) drafting and submitting a preliminary guideline about the management of “orphaned”
LTOT patients to our operations partners on this project. Next steps/Implementation: The next step in this
research program will be a multi-site project to examine the extent to which use of the screening tools and
potential CPG, resulting from this proposed study, is associated with improved patient outcomes (e.g., fewer
overdoses), and health care system utilization and costs (e.g., fewer emergency department visits and
hospitalizations for opioid-related acute crises). Next steps also include partnering on quality improvement
projects to implement the screening tools and CPG in VA primary care and pain clinics.

Public health relevance
Many VA patients receive long-term opioid therapy (LTOT). LTOT may be harmful, and so physicians are supposed to frequently monitor LTOT patients. However, many LTOT patients are not frequently monitored, and many are having LTOT discontinued, even though discontinuation may also be harmful. Because of potential harms of LTOT, difficulties of frequent monitoring, and potential harms of having LTOT discontinued, physicians need practical tools and guidelines to improve care. This project will improve patient care by developing integrated screening tools to indicate if LTOT is harmful to continue (yes or no), and if tapering to discontinue opioids is harmful to initiate (yes or no). When the tool indicates “yes,” this will mean that physicians should start additional, more comprehensive monitoring and examination to determine the harms and benefits of continued LTOT or of tapering to discontinuation. This project will also identify preliminary treatment approaches for an at-risk subgroup of LTOT patients: those who screen “yes” on both tools.